Gpr68 modulation of myofibroblast dynamics during tendon healing

Following injury, tendon heals via a fibrotic scar-mediated process. This fibrotic response impairs restoration of
tendon structure and function, and there are currently no pharmacological approaches in standard use to
enhance the healing process. While the overall cell environment during healing is dynamic and complex,
myofibroblasts are key regulators of the healing process. During tendon healing, tenocytes undergo
progressive activation and differentiation in to myofibroblasts. Myofibroblasts synthesize, contract and remodel
the new extracellular matrix that is required for restoring tissue integrity. However, resolution of physiological
healing requires clearance of myofibroblasts, either via apoptosis or reversion to a basal fibroblast/tenocyte
state. Tissue fibrosis, including fibrotic tendon healing results from myofibroblast persistence. Indeed, we have
previously shown that tendon scar tissue from both mouse and humans is enriched for myofibroblasts that take
on an anti-apoptotic profile. As such, understanding the mechanisms, and identifying therapeutic approaches
to modulate myofibroblast dynamics during healing would fill critical knowledge gaps. We and others have
recently demonstrated that expression of the proton-sensing G-protein coupled receptor Gpr68/Ogr1 is
decreased during tissue fibrosis. Moreover, small molecule activation of Gpr68 can modulate both
myofibroblast differentiation and reversion of lung fibroblasts. Thus, in this high-risk high-reward proposal we
will define the efficacy of pharmacological activation of Gpr68 to modulate tenocyte-myofibroblast dynamics
during fibrotic tendon healing. In addition, our preliminary data suggest that changes in macrophage-specific
Gpr68 expression during healing underpin several aspects of myofibroblast function. The on-going interaction
between macrophages and myofibroblast is an important regulator of both physiological and fibrotic wound
healing. Therefore, we will dissect the cell-type specifics functions of Gpr68 in modulating tendon healing, and
in responding to small molecule activation of Gpr68. Successful completion of these studies will provide
important fundamental information related to regulation of the cell environment during tendon healing, and will
establish a novel pharmacological approach to enhance the tendon healing process.

Public health relevance
Myofibroblasts are a key regulator of tendon healing as they synthesize and remodel the new extracellular matrix. However, proper resolution of healing requires myofibroblast clearance via apoptosis or reversion to a basal fibroblast state. Here we will test the efficacy of small molecule activation of Gpr68 as a means to modulate myofibroblast differentiation and reversion and enhance the tendon healing process.